CFTR and Vascular endothelial function

Abstract
Misfolded/dysfunctional cystic fibrosis transmembrane conductance regulator
(CFTR) protein causes multiple health related issues including lung disease and
diabetes in cystic fibrosis (CF). Scientific advancements have significantly prolonged the
life span of CF patients. But aging promotes endothelial dysfunction. Importantly, CF
patients are known to have impaired endothelial function. Therefore, it is likely that
endothelial dysfunction will worsen with age in CF patients. However, how CFTR
regulates endothelial function and thereby vascular tone is not known. It is not known
whether CFTR modulators are effective against CF-associated endothelial dysfunction.
Therefore, it is important to understand the significance of CFTR in endothelial function
and to assess the impact of aging on endothelial function in CF patients.
Our preliminary data suggests that like CF patients, deletion of CFTR or
expression of dysfunctional CFTR exhibit impairment of endothelium-dependent
relaxation of coronary arteries in pigs. Even acute pharmacological inhibition of CFTR in
mice aortic rings leads to endothelial dysfunction. We have also noted that genetic
deletion of CFTR or pharmacological inhibition of CFTR downregulates endothelial nitric
oxide synthase (eNOS) expression in endothelial cells. As aging promotes endothelial
dysfunction and downregulation of eNOS levels, we propose to evaluate the changes in
endothelial function and examine the mechanism involved in CFTR-mediated regulation
of NO production with aging. We will use a novel mouse model of CF disease with
endothelial deletion of CFTR (e-CFTR-/-) to determine: 1) whether aging-induced
endothelial dysfunction accelerates with endothelial deletion of CFTR and 2) the eNOS-
CFTR regulation as a mechanism mediating the CFTR-dependent regulation of
endothelial function. We will examine vascular function in aged mice having endothelial
deletion of CFTR. We will also use cell biology-based assays to determine the
functional changes in the endothelial cells due to CFTR and possible ways to modulate
such effect. This study will demonstrate the impact of aging on endothelial dysfunction
due to loss of CFTR function.

Public health relevance
Project Narrative People having cystic fibrosis have problems in their blood vessels and this is expected to increase with age. This is an exploratory study to examine why cystic fibrosis patients have problems in their blood vessels. This study will identify the cause of blood vessel disease in cystic fibrosis patients which will be helpful in treating vascular diseases in CF patients.